Neural ElectroMagnetic Ontologies: ERP Knowledge Representation & Integration

Description (provided by applicant): Research in the design and implementation of "Neural ElectroMagnetic Ontologies" (NEMO) will address a critical need for tools to support representation, storage, and sharing of brain electromagnetic data. Electro- encephalography (EEG) and event-related potentials (ERP) are venerable techniques for cognitive and clinical research on human brain function. To realize their full potential, however, it will be necessary to address some long-standing challenges in comparing results across experiments and research laboratories. NEMO will address this need by providing ERP ontologies that can be used for meta-analysis of patterns across experiment contexts and research labs. Given the widespread use of EEG and ERP methods, and their clinical as well as research applications, development of such a system is both timely and significant. System design and implementation will rest on six specific aims. The first goal is to develop rigorous procedures for classification and labeling of electrophysiological patterns (event-related potentials, or ERPs) (Aim 1). The methods and tools that are developed initially for classification and labeling of surface (sensor- level) data will then be extended to support classification of data in source (anatomical) space (Aim 2). Next, we will represent the concepts that define ERP patterns as formal logics, or "ontologies," and will use those concepts to describe the ERP patterns. Relational databases will be modeled based on the ontologies to support high-level questions about the nature of ERP patterns and the relationships between patterns that are associated with different lab, experiment, and analysis contexts (Aim 3). The application domain for our project is reading and language. We have established a consortium of experts in this area who will contribute EEG and ERP data from experimental studies and will collaborate with us on the design and testing, and evaluation of the tools developed for this project. The practical scientific aim will be to conduct meta-analyses of ERP patterns in reading and language. In addition to re-analyses of existing cross-lab data, new experiment paradigms (adapted from the fBIRN project) will be carried out across research sites to calibrate data acquisition and preprocessing methods, and to test the robustness of patterns across different experiment contexts (Aim 4). Initially, we will develop a different ontology for each representational space (e.g., sensor and source space) and each analysis method. Then, we will capture the semantic mappings between different sets of patterns (different ontologies) using data mining (Aim 5). To support this work, we will develop an integrated tool environment for storage and management of EEG and ERP data and meta-data, measure generation and labeling, ontology development, and meta-analysis. This environment will be web-accessible so that partners will have shared access to the project data, analysis tools, ontologies, and meta-analysis results (Aim 6). At the end of this project, the ontologies, annotated database, tools, and technologies will be made available to the larger research community. PUBLIC HEALTH RELEVANCE The practical goal for the NEMO project is to build an ontology database to support data sharing and meta- analysis of EEG and ERP results. The ability to describe brain electrophysiological patterns from different research laboratories and different experiment contexts within a common framework will have immediate benefits for the neuroscience community, as well as long-term benefits for neuroscience research and for scientific areas with similar requirements for robust data representation and integration, and data and resources sharing.

Public health relevance
Relevance The practical goal for the NEMO project is to build an ontology database to support data sharing and meta- analysis of EEG and ERP results. The ability to describe brain electrophysiological patterns from different research laboratories and different experment contexts within a common framework will have immediate benefits for the neuroscience community, as well as long-term benefits for neuroscience research and for scientific areas with similar requirements for robust data representation and integration, and data and resources sharing. 1